MOLECULAR MESSENGERS THAT UNDERLIE NEUROTOXIC AND OTHER ACTIONS OF DRUGS OF ABUSE

Our proposal investigates molecular messengers that underlie neurotoxic and other actions of drugs of abuse. Specific areas covered in the research plan are neurotoxic influences of nitric oxide signaling, glyceraldehyde-3 -phosphate dehydrogenase and heme oxygenase/biliverdin reductase. Additionally, we will continue studies of D-aspartate as a neuromodulator and mediators of cell stress such as p53, areas which, for the sake of brevity, are detailed separately in the Progress Report.